Advancing Techquity: Optimization of the FAITH! App for Dissemination to Promote Cardiovascular Health among African Americans

ABSTRACT
Digital health interventions are efficacious in improving cardiovascular health (CVH) and cardiovascular (CV)
outcomes. Mobile technologies such as smartphones are used frequently to access health information,
especially by African-Americans (AAs). However, there is a paucity of effective, culturally relevant, evidence-
based interventions available. Leveraging community-based participatory research (CBPR), the FAITH!
(Fostering African-American Improvement in Total Health!) Program, led by Dr. LaPrincess Brewer, co-
designed a culturally tailored CVH-focused mobile health (mHealth) intervention alongside AA community
members. The community-informed FAITH! App was then tested in an American Heart Association, National
Institutes of Health-funded cluster randomized clinical trial (RCT), the FAITH! Trial, among participants
(N=85) from predominantly AA churches in Rochester and the Minneapolis-Saint Paul (MSP), Minnesota
metropolitan areas. The study found that the FAITH! App resulted in significant improvements in CVH scores
and behaviors (diet, physical activity). Participants viewed the app as equitable for CVH education and
suggested optimizing our web-based mHealth tool into a smartphone app. Our overarching goal is to
enhance the FAITH! App to serve as a versatile, scalable platform to extend the reach of the FAITH! program.
To achieve this goal, our Small Business (CareEvolution)/Academic Partner (Mayo Clinic, FAITH!)
team proposes 2 aims: Aim 1 will analyze participant feedback previously obtained from a mixed-methods,
formative evaluation of the web-based FAITH! App intervention in the FAITH! Trial Cohort. Primary outcomes
are app usability, acceptability, and satisfaction by participants. Aim 2 will optimize the FAITH! App through
synthesis of findings of the intervention formative evaluation and human-centered design sessions with
community members. We will develop an optimized, smartphone-based FAITH! App with improved user
experience, usability, and potential for global dissemination through partnerships with key strategic
stakeholders and academic institutions for decentralized health monitoring and clinical data collection.
Primary outcomes include optimized app usability, acceptability, and satisfaction. Our project is innovative in
that it offers a community co-designed, culturally tailored tool for CVH promotion for AAs, a niche and
population often overlooked by generic lifestyle apps. More importantly, following CBPR principles and the
NIMHD Health Disparities Research Framework, this proposal leverages an academic-community-business
partnership (Mayo Clinic-FAITH!-CareEvolution); thus, ensuring that the community’s priorities and
preferences are central to the development of the optimized FAITH! App. Synergy between FAITH! and the
CareEvolution innovative, multimodality platform, MyDataHelpsTM will catalyze the achievement of the Phase
1 proposal objectives.

Public health relevance
PROJECT NARRATIVE Digital health interventions are efficacious in improving cardiovascular health (CVH) and cardiovascular (CV) outcomes. Mobile technologies such as smartphones are used frequently to access health information, particularly among African-Americans, who face a disproportionate burden of CV disease. Our proposed study aims to enhance an existing culturally tailored, evidence-based, mobile health (mHealth) intervention (FAITH! App) for CVH promotion for AAs through: 1) analysis of participant feedback previously obtained from a mixed-methods, formative evaluation of the FAITH! App intervention in the FAITH! Trial Cohort and 2) optimization of the FAITH! App in the MyDataHelpsTM platform through synthesis of findings of the formative evaluation and a human-centered design session series with community members and the Small Business (CareEvolution)/Academic (Mayo Clinic) Partner team.